A Cognitive Risk Calculator and Screening tool for Primary Care Settings

PROJECT SUMMARY/ABSTRACT
The number of people with Alzheimer’s disease is expected to exceed 88 million by 2050. Early
detection of Alzheimer’s disease and related disorders symptoms are imperative for efforts to develop
disease modifying therapies or interventions, and are important for optimal patient care. The objective
of this proposal is to provide an accurate, feasible, and low-cost process to facilitate cognitive screening
in population health.
The aims of the R61 project are to develop and validate two complementary, automated tools to identify
and screen patients at high risk for cognitive decline. The first is a risk calculator that uses routine
clinical data to estimate patients’ risk for cognitive decline. Patients 60 years and older will undergo
formal cognitive testing, and five prior years of routinely-collected electronic health record data will be
used to model cognitive status. The Cognitive Risk Calculator will be validated in two historical samples
and integrated into the electronic medical record to help providers identify vulnerable patients.
The second tool is a validated iPad-based screening tool, the Brief Assessment of Cognitive Health
(BACH) that patients can complete independently before, during, or after their doctor appointment.
Patients will complete the BACH, the Montreal Cognitive Assessment Test (a paper-and-pencil
screening tool), and formal neuropsychological testing at two time points. We hypothesize the BACH
will be more sensitive to cognitive change over time than the established screening tool. The BACH is
already integrated into the Epic electronic medical record platform; cognitive score and screening
results for depression, stress, and sleep disruption are automatically recorded in the patient’s medical
record for providers to document and act upon.
The R33 project is a Phase IV pragmatic clinical trial to gauge the uptake and utility of these tools in
primary care practices. Six internal medicine clinics will be randomized over time to the active study
arm (Risk Calculator and BACH). This will permit comparisons of standard of care screening practices
with screening activities following introduction of the Cognitive Risk Calculator and BACH. We will use
a mixed-methods approach to determine optimal implementation strategies across a variety of practice
models.
Impact: The EHR risk-calculator and BACH have the capacity to improve detection of cognitive decline
on a population health scale. The project also examines how regional differences in socioeconomic
advantage relate to health disparities measured in terms of cognitive risk as well as screening attitudes
and behaviors on the part of both providers and patients.

Public health relevance
PROJECT NARRATIVE Population health protocols lack efficient and effective methods to screen cognitive health. The tools proposed in this research may provide a low-cost, scalable method to improve detection of cognitive decline.